Prenatal Exposure to Endocrine Disrupting Chemicals and Risk of Testicular Cancer (DISRUPT)

§
Project Summary
Testicular cancer, although rare in the general population, represents around 60% of all cancers in young
men aged 20-40 years. Its incidence has increased several-fold during the 20th century, but reasons for this
are largely unknown. Established risk factors include cryptorchidism, Caucasian ethnicity as well as family
history of testicular cancer and scientists strongly suspect that environmental exposures particularly during
fetal development may play a role. The endocrine disruption hypothesis suggests that exposure to endocrine
disrupting chemicals (EDCs) during fetal development disrupts normal reproductive organ development
associated with long-term adverse reproductive effects, including testicular cancer. Despite heightened con-
cern and tremendous scientific and public attention during the past 20 years, epidemiological data are still
sparse. The conditions rarity in the population, long lag time between the sensitive period during fetal de-
velopment and clinical appearance and lack of appropriate animal models for testicular cancer have hin-
dered the understanding of the factors involved in the development of this cancer and few if any studies
have quantified prenatal exposure to EDCs and were unable to address risk of testicular cancer from fetal
exposures. Therefore, there is a need for epidemiological based research with reliable data based on expo-
sure assessment quantified in biological prenatal samples, which are considered the gold standard. The
objective of the present proposal is to address this knowledge gap using a cohort of 128,702 women who
provided blood and amniotic fluid samples during their pregnancies in the period 1976-96. By registry link-
age within highly reliable national population and disease registries for ascertainment for outcome/poten-
tial confounders we will identify all sons diagnosed with testicular cancer (including sub-types) and match
each of these at the time of their diagnosis to two control sons (n=550 sons) using risk set sampling. Levels
of EDCs including DDT, DDE and other organochlorine pesticides, PCBs, PBDEs, PFAS, phthalates and
triclosan will be quantified in prenatal biosamples from mothers. This study is important in relation to the
overall mission of the National Institute of Environmental Health Sciences and will contribute substan-
tially to the weight of the evidence in support of or against the fetal programing hypothesis with respect to
testicular cancer and environmental EDCs. No similar research has been carried out in the US. Elucidating
the association between relevant environmental EDCs and testicular cancer may reveal potentially modifia-
ble risk factors, leading to guidelines for pregnant women so they can take sensible measures to reduce their
own exposures.

Public health relevance
Project Narrative The incidence of testicular cancer has increased several-fold in all industrialized countries during the 20th century, but reasons for this trend remain unknown and cannot be explained by established risk factors. The proposed research project will investigate the effects of maternal exposure to endocrine disrupting chemicals on risk of testicular cancer in offspring; representing one of the few opportunities to determine association of prenatal endocrine disrupting chemical exposure on testicular cancer. The present NIH call criteria specifies: The purpose of this Funding Opportunity Announcement (FOA) is to stimulate research focused on the role of early-life factors (maternal-paternal, in utero, birth and infancy, puberty, adolescence, and young adult years) in cancer development later in life. Thus our proposed research project is directly relevant to the mission of the National Institute of Environmental Health Sciences and, at the same time, the results of this Danish study can be directly extrapolated to the U.S.